INBRE-2 UAA RESEARCH CORE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The Research/Instrument Core of INBRE-2 is set up to support faculty at all three campuses. It will be used for research technicians, service agreements, supplies, travel, and additional support. The research cores also include research funds for developmental and affiliate faculty;use of these funds are covered in the Progress Reports for the individual subprojects.